Novel Device to Optimize Aerosol Drug Delivery for Pulmonary Hypertension Treatment

Abstract
Aerosol inhalation therapy is one of the cornerstones of respiratory therapy. The size of airborne
particles determines their deposition pattern within the lungs and therefore, the efficacy of
inhalation therapy. In this Phase 2 SBIR project, BridgeSource Medical (BSM) proposes to
develop a breath-adaptive nebulizer with variable aerosol droplet sizes and actuation times.
This can be used to administer precise doses of pharmaceutical drugs to the pulmonary system
with much greater efficiency than currently available aerosol delivery devices like small-volume
adaptive aerosol delivery (AAD) nebulizers that require strict patient breath timing, but do not
vary droplet size. The nebulizer would be particularly beneficial in the administration of
medications to treat elderly patients with respiratory conditions such as pulmonary hypertension,
where long treatment times and strict requirements on patient breathing lead to poor
compliance. The ultimate goal will be to develop a clinical tool that would be approved by the
Food and Drug Administration (FDA) as an effective system to nebulize several drug
formulations targeted for patients who cannot easily comply with strict breathing maneuvers,
such as the those with advanced lung disease such as pulmonary hypertension.

Public health relevance
Project Narrative Respiratory disorders affect over 10% of the US population and can be better managed using an aerosol delivery device that does not depend on specific breathing patterns that are difficult to execute, especially by elderly patients. Such a device can be used to optimize administration, and positively effect compliance in pulmonary hypertension, improving outcomes.